Core D: Neuropathology Core

ABSTRACT
The UCSF ADRC Neuropathology Core (Path Core) provides vital research support to the UCSF ADRC and to
the neurodegenerative disease research community at UCSF and beyond. Neurodegenerative disease
pathology has become increasingly exciting and complex in recent years, with major advances arising from
work accomplished through this ADRC. In this application, the Path Core will continue to be led by Dr. William
Seeley and co-led by Dr. Lea Grinberg. The Path Core aims to: (1) Obtain and bank human brain and spinal
cord tissue for neuropathological characterization and research; (2) Analyze specimens and render
neuropathological diagnoses; (3) Review tissue requests and distribute specimens; (4) Support innovative
neuropathological approaches; (5) Train the next generation of neurologists and neuropathologists conducting
research on neurodegenerative disease. These goals will be accomplished through extensive interactions with
the other cores of the UCSF ADRC and will have a major impact on the overall success of the center.